Connecting Molecular and Cellular Contractile Dysfunction in Cardiomyopathy

Project Summary/Abstract
Cardiomyopathies are major causes of heart failure and sudden death, and they represent a common indicator
for heart transplantation. Current therapies have focused on “one-size-fits-all” approaches that improve
outcomes in some patients, but not others. Therefore, there is an outstanding need to develop new treatment
strategies that improve outcomes for patients. It has been hypothesized that patient outcomes could be
improved by taking a precision medicine approach that considers genotype for treating cardiomyopathies;
however, it is not clear whether such an approach would be beneficial, and if so, how to best implement this
approach. This approach remains unrealized, in part, due to fundamental challenges connecting genotype,
phenotype, and treatment options. Here, we will take the critical first steps towards investigating the feasibility
of a mechanism-based precision medicine approach by focusing on cardiomyopathy mutations in troponin.
Specifically, we will use an innovative combination of biochemical, biophysical, cell biological, and tissue
engineering techniques to begin to build a mechanistic understanding of the connections between genotype,
molecular and cellular dysfunction, and small molecules that potentially reverse molecular dysfunction for key
troponin cardiomyopathy mutations. We have engineered model systems of patient-specific mutations that span
from molecules to tissues that enable us to 1) understand the fundamental molecular biophysical mechanisms
driving disease pathogenesis for key troponin mutations and 2) probe how molecular dysfunction affects cellular
and tissue function in human cells. We will leverage these models to answer the following questions for several
key troponin mutations: 1) Is it possible to bin patient mutations into subgroups with common molecular
dysfunction? 2) Is it possible to use knowledge of molecular mechanism to identify compounds that reverse the
molecular dysfunction of patient-specific mutations? 3) Does reversal of the underlying molecular dysfunction
improve cellular and tissue function? The results of these studies will set the stage for the development of new
approaches for treating cardiomyopathies.

Public health relevance
Project Narrative Familial cardiomyopathies are major causes of heart failure and sudden death, and while current therapies focused on “one-size-fits-all” approaches have improved outcomes in some patients, many others do not respond to these treatments. We have developed a unique toolset that will enable us to test whether it is possible to use mechanistic knowledge about the relationships between genotype and phenotype to identify potential therapeutics for patient-specific mutations. This precision medicine approach would enable the tailoring of therapeutics to subgroups of patients that are not adequately treated by current approaches.